Transcriptomic and proteomic analyses of Upc2A under Candida glabrata hypoxic growth

Adaptation to hypoxia is crucial for human pathogens like Candida glabrata, since the condition
mimics the infection environment inside the host. Hence, our long-term goal is to identify
essential factors that are required for C. glabrata hypoxic growth, and to exploit them for novel
Candida drug development. However, the transcriptional responses of C. glabrata shifting from
normoxic respiratory to hypoxic metabolism is unexplored. My recent work has indicated that
the transcription factor Upc2A is activated hypoxically, and its function is essential for C.
glabrata hypoxic growth. Although Upc2A roles in C. glabrata drug resistance mechanism is well
characterized, its intrinsic function in C. glabrata biology remains under-studied. This application
takes an interdisciplinary approach combining cutting-edge next generation sequencing,
proteomics, and molecular genetic techniques to determine the fundamental function of Upc2A
in C. glabrata hypoxic physiology. Our overall objectives are (i) to decode the comprehensive
interaction networks of Upc2A target genes as well as genes that are required for C. glabrata
hypoxic adaptation, and (ii) to identify Upc2A-associated proteins required for the activity of this
transcription factor and the organism’s hypoxic growth. This knowledge will provide more
understanding about C. glabrata physiology under hypoxic growth conditions which could
ultimately be translated into the pathogenesis of this organism inside the host.